Cumulative Life Course Effects on Aging and Health in a Long-Lived Primate Model

PROJECT SUMMARY
Life course theory emphasizes that aging is a trajectory that starts early in life, and as such, individual
heterogeneity in aging is rooted in a lifetime of health exposures and the environments in which we live. This
perspective is critical for understanding the nature and modifiability of health inequalities among the aged.
However, it has been extraordinarily difficult to put life course perspectives into practice, owing to the long
timeframes necessary to study humans and the difficulty of operationalizing relevant features of human
environments. We propose that these problems can be rectified by studying an underused model system,
chimpanzees. This research extends a longitudinal study aimed at investigating the biology of aging in
chimpanzees, one of our closest living relatives and a critical link for reconstructing how the human aging
process evolved. This close evolutionary relationship results in genetic and physiological similarities that are
not represented by common laboratory animal models. Chimpanzees are socially-complex and long-lived,
meaning that they are particularly well suited to study how environmental factors such as the chronic burden of
infection, social support, and social inequality yield health effects across a lifetime. In our first funding period,
we validated a robust toolkit of non-invasive biomarkers of health and aging and used longitudinal sampling of
chimpanzees to establish how the chimpanzee aging process compares with humans. In the renewal period,
we build on those successes by addressing the multidimensionality of our longitudinal health data. Aim 1 will
extend the longitudinal health monitoring and biosampling of our original sample and increase the sample to a
total of 350 wild and 200 free-ranging chimpanzees. We will also develop accessible resources for comparative
aging research. Aim 2 will examine the hypothesis that the cumulative burden of infection across life is a
significant determinant of individual heterogeneity in aging. The immune system plays a pivotal role in the
aging process and has complex feedbacks on other aspects of senescence. Yet, the long lifespans of humans
evolved in environments where infectious challenges to the immune system were persistent. In wild
chimpanzees, we can study these dynamics in a system without medical intervention and where other age-
related pathologies are rare. Aim 3 builds upon Aim 2 by examining the hypothesis that social processes
modify aging trajectories. We are particularly interested in understanding the mechanisms by which social
support and status from early adulthood, when they are first established, contribute to later life health
disparities, and whether these impacts can be further modified by age-related shifts in social behavior.
Chimpanzees in our study populations have been closely observed for most or all of their adult lives, providing
a rare opportunity to apply objective, detailed social histories to the study of aging in the absence of major
lifestyle factors that complicate human studies.

Public health relevance
PROJECT NARRATIVE Aging is a process that is shaped by experiences across the life course, such as social inequality and social support, yet the ability to quantify individual experience over the long human lifespan remains a hindrance to aging research. Chimpanzees, a long-lived species with close genetic and physiological similarities to humans, offer a tractable way to approach life course studies due, in part, to decades of detailed, objective observations conducted on the two longest-studied populations in Africa. Building on an initial study that developed and validated non-invasive measures of health and aging in wild chimpanzees, these aims will investigate the cumulative influences of infection and social processes on health and mortality outcomes.